tRNA Epitranscriptome and Translational Dysfunction in ADRD

This proposal examines tRNA modifications in Alzheimer’s Disease (AD) and Related Disorders (ADRD). tRNA is
important because the amount of protein produced in a cell depends on tRNA availability and function, both of which are
highly regulated. tRNA biology is complicated but demands investigation. Humans have up to 12 tRNAs (termed
isoacceptors) for each amino acid, with some tRNAs able to interact with different codons depending on the tRNA
modification; thus, there are ~250 different tRNAs. Each tRNA is regulated by up to 50 different kinds of modifications with
up to 10 modifications per each tRNA molecule. These modifications control tRNA levels and codon specificity. Our
preliminary results from the PS19 P301S MAPT ADRD mouse model reveal >25 tRNA modifications in degenerating brains
that exhibit dysregulation (up or down) disproportionate to aging. For instance, we observe increased levels of tRNA
modifications such as 2’-O-methyl-adenosine (Am), and decreased modifications such as queusine (AD vs. controls).
Proteomic studies show corresponding changes in the enzymes producing the modifications. Studies of bacteria, yeast, and
cell lines show that the tRNA epitranscriptome and tRNA pool change with stress, which modifies the speed of tRNA
translation for particular codons (termed codon bias), whic modifies the pattern of protein synthesis. Indeed, our results show
striking levels of codon bias that correlate with the major changes in brain proteomes of the mouse AD model and human
AD. In states of dysfunction, mismatches between codon usage and tRNA modification or abundance can dramatically alter
tRNA translation which can enhance pathological protein misfolding. We hypothesize that disease stresses alter the system
of tRNA modifications and tRNA levels, contributing to mistranslation, protein misfolding, and proteotoxic stress, which
can be ameliorated by genetic modulation of tRNAs and modification writers. The hypothesis is addressed with three aims,
delineating tRNA metabolism and then testing effects of observed changes with forward genetics. Aim 1 will determine
patterns of tRNA expression and modifications associated with disease states in European (EU) and African American (AA)
cases in PFC. We will characterize how the levels and modifications of tRNAs change with disease stage among EU and AA
brains collected from the highly characterized ROSMAP cohort. Results will be cross-correlated with A) neuropathologies,
B) insoluble protein levels, including Tau, A, TDP-43, and SNCA (Aim 2), C) disease-linked genetic polymorphisms (e.g.,
ApoE), and D) other endophenotypes available on NIA genomic, proteomic, clinical and imaging databases. Aim 2 will
characterize codon biases in genes for soluble and insoluble proteomes in ADRD disease states among EU and AA cases.
Major pathologies will be examined as outcomes. Aim 3 will determine whether manipulating tRNA modifications or codon
bias alters the aggregation of Tau, TDP-43, or other elements of the insoluble proteome. The aim begins by measuring tRNA
half-life in 3D human neuron/astrocyte assembloids (which develop AD pathology) in basal conditions (A) or with stress
(B). Then we will (C) use forward genetics in 3D iPS-N/A to correct disease-linked activity changes of tRNA-modifying
enzymes implicated or identified in Aims 1 & 2. We will also test if human iPSC lines CRISPR’d with synonymous codon
(i.e., silent) mutations modulate AD-linked changes in levels or solubility of proteins linked to ADRD.

Public health relevance
This proposal will characterize how modification of tRNA changes in Alzheimer’s disease. We will identify which changes are most important for AD and how the changes vary among individuals with European or African American Ancestry. The results will deepen our understanding of the disease process and potentially identify novel biomarkers and/or therapeutic targets.